2024 Colloidal, Macromolecular and Polyelectrolyte Solutions Gordon Research Conference and Seminar

Project Summary
Colloids, macromolecules and polyelectrolytes serve as building blocks for biological and synthetic materials
with microstructures that are often far from equilibrium. Such complexity and diversity give rise to unique
properties with endless potential for innovation. Recent advances in characterizing and precisely controlling
their structure and properties are enabling a wide array of applications from novel delivery vehicles to green
materials to living and non-living systems that may provide insights into the origins of life. Due to the intricate
nature of these systems, their study requires a unique approach involving a combination of experiments and
theoretical analyses. The 2024 Gordon Research Symposium (GRS) and Gordon Research Conference
(GRC) on Colloidal, Macromolecules and Polyelectrolyte Solutions aims to explore the innovation of these
materials and techniques for their characterization, focusing on engineering diverse soft matter systems by
bringing together scientists with diverse backgrounds and expertise. The GRS is a student and postdoc
organized and led conference that takes place the weekend prior to the GRC. The GRC and GRS organizers
have a strong commitment to supporting students, postdocs and early career scientists. These conferences will
also enhance diversity, equity and inclusion by ensuring representation in our invited speakers and discussion
leaders, increasing participation by advertising to professional societies and minorities serving institutions and
a strong commitment to creating safe and welcoming environments. The scientific topics covered by the GRS
and GRC align with the mission of the National Institutes of Health (NIH) and, specifically, the National Institute
of Biomedical Imaging and Bioengineering (NIBIB). The topical focus of these conferences is colloidal,
macromolecular and polyelectrolyte solutions. These highly engineered materials are used in a broad range of
applications and we have invited speakers that highlight these areas. Sessions that fit into these missions
include 3D printing and additive manufacturing with a focus on biomaterials, novel delivery vehicles, origins of
life with a focus on biological development including disease progression and bio-inspired and biomimetic
materials. Other sessions include speakers that develop new technologies and work that enhances
fundamental understanding that underlies the detection and treatment of diseases. By inviting speakers that
range from fundamental to transformational work we plan to not only showcase NIH relevant and funded
research but also anticipate new connections and collaborations between scientists. Exploiting the GRC format
which provides ample time for informal conversation, a goal of these conferences is to seed ideas that lead to
new projects that would be of interest to NIH and NIBIB.

Public health relevance
Narrative The 2024 Gordon Research Symposium (GRS) and Gordon Research Conference (GRC) on Colloidal, Macromolecules and Polyelectrolyte Solutions aims to explore the innovation of these materials and techniques for their characterization, focusing on engineering diverse soft matter systems. These conferences will bring together scientists with diverse backgrounds and expertise with a strong commitment for supporting students, postdocs and early career scientists. The GRS and GRC will also enhance diversity, equity and inclusion by ensuring representation in our invited speakers and discussion leaders, increasing participation by advertising to professional societies and minorities serving institutions and a strong commitment to creating safe and welcoming environments.